Mentoring Patient Oriented Research in Innovative Imaging and High-dimensional Data Approaches to Improve Outcomes in Cardiac Amyloidosis

Project Summary/Abstract
Dr Sharmila Dorbala is an Associate Professor of Radiology at Harvard Medical School and a physician/scientist
at Brigham and Women's Hospital (BWH). She has devoted her career to patient-oriented research focusing on
cardiac amyloidosis. She contributed independently to the field of cardiac amyloidosis through a succession of
substantive studies utilizing molecular imaging to phenotype cardiac amyloidosis in order to diagnose and
manage this condition. Her research program is impactful, both directly and through effective mentoring of the
next generation of amyloidosis investigators. Dr. Dorbala has successfully mentored 26 pre- and post-doctoral
trainees in patient- oriented research projects. She is currently PI of two active NIH R01 grants and also has
funding from AHA and foundation/industrial sources. Her program provides a unique opportunity for POR due
to the intersection of resources from programs in clinical investigation at the Harvard School of Public Health
and the BWH cardiovascular imaging T32 program. Her mentees have presented their work nationally and
internationally, published papers, and won research awards and pilot grants.
The new research aims proposed in this award lay the foundation for adjunct interventions to enhance
transthyretin cardiac amyloidosis (ATTR-CA) therapies and novel image-based personalized strategies to predict
treatment failure. She will assess (1) sonoporation, a therapeutic ultrasound technique to increase myocardial
perfusion and, consequently, improve delivery of antifibril drugs; (2) shotgun metagenomic sequencing of the
gut microbiome to inform development of nutrition-based adjunct therapies; (3) radiomics of 99mTc-
pyrophosphate SPECT/CT to assess treatment response, and (4) machine learning based CT-derived sarcopenia
metric to predict survival. This research has important clinical implications. Currently approved TTR
stabilizing/silencing drugs, though lifesaving for most, are not effective in about 30% of patients. Moreover,
while these therapies improve clinical outcomes, they do not treat amyloid fibril. Fibril-targeted therapies have
been unsuccessful to date, probably because of poor interstitial drug delivery due to the presence of fibril. The
results of the proposed mentoring and research activities of this K24 project are likely to not only substantially
improve outcomes and alleviate HF symptoms in these gravely ill patients, but also transform her patient-
oriented research program into a formal individualized program of mentoring with a focus on preventing heart
failure from amyloidosis.

Public health relevance
Project Narrative Transthyretin cardiac amyloidosis, a particularly deadly form of heart failure, can now be treated by recently developed medications. The proposed projects will develop new heart imaging approaches to determine who is likely to respond to the new medicines, test a new ultrasound-based therapy to improve blood flow to the heart muscle and thereby improve delivery of novel drugs to the heart, and study bacteria in the stool with the goal of eventually developing diet-based strategies to address cardiac amyloidosis. In developing methods to improve treatments for amyloidosis, this project will support expansion of Dr. Dorbala’s patient oriented research program and enhance training for her mentees.